Viral Testing Core

Abstract – Core B: Viral Testing Core
The Viral Testing Core is a critical component for the maintenance of a Specific Pathogen Free (SPF) Indian
rhesus macaque (Ind RM) (Macaca mulatta) breeding colony. Rhesus macaques infected with the Simian
Immunodeficiency Virus (SIV) are the preferred animal model for AIDS studies and are used to examine many
aspects of viral pathogenesis, AIDS vaccine development, and exploratory new systemic and mucosal antiviral
therapies, including early events not readily studied in human patients. The presence of certain viruses can
confound the results of AIDS-related investigations. SPF colonies have been developed using state-of-the art
assays to eliminate animals with simian immunodeficiency virus (SIV), Type D simian retrovirus (SRV) simian T-
lymphotropic virus (STLV-1); and herpes B virus (Macacine herpesvirus-1), which is a potential health risk for
personnel handling the animals. The goal of the Viral Testing Core is to provide techniques and expertise to
assure the continuing SPF status of the Ind RM breeding colony at the Southwest National Primate Research
Center (SNPRC). In order to fulfill this goal, the following Specific Aims will be completed: Specific Aim 1: to
provide a reliable and sensitive in-house viral screening method. This screening method is intended to produce
reliable results in a fast turnaround time. We will continue to use the Charles River Laboratories (CRL) Multiplex
Fluorescent ImmunoAssay (FMIA) for serological screening of all animals, which represents one of the current
state-of-the-art surveillance techniques. Specific Aim 2: to increase the research value of the SNPRC Ind RM
breeding colony by expanding serology testing. The core is ever evolving in the use of state-of-the-art techniques
and expanding to detect other pathogens of interest. In recent years, we extended our serology testing to include
detection of antibodies against measles virus and Trypanosoma cruzi. Presence of antibodies to measles is used
to confirm immune responses to the colony active measles immunization effort. Serological screening for
antibodies to the causative agent of Chagas Disease, along with PCR confirmatory testing, is used to 1) assist
animal selection; 2) to determine the prevalence of this infection in the NHP colonies; and 3) to improve and
evaluate the effectiveness of our pest control system. Finally, SNPRC has recently screened the SPF colony for
SARS-CoV-2 by both serology and PCR. Following recommendations developed by the National Primate
Research Center Pathogen Detection Working Group, the Viral Testing Core has developed an algorithm that
incorporates results from the serological viral screening with both serological and PCR confirmatory assays.
Additionally, the Core will continue to participate in activities proposed by the national Breeding Colony
Management Consortium (BCMC), which frequently distributes serum panels for proficiency testing among its
laboratory members with the intent to monitor and ensure acceptable quality testing algorithms, reagents,
methods, equipment, and personnel.

Public health relevance
Narrative – Core B: Viral Testing Core Southwest National Primate Research Center (SNPRC) maintains an Indian origin rhesus macaque (Ind RM) colony that is Specific Pathogen Free (SPF) for SLTV-1, SIV, SRV, and BV to ensure that there is a ready supply of these NHPs for HIV research. In addition, SPF RM are serologically tested for both the parasite Trypanosoma cruzi and for measles antibodies titer to evaluate the efficacy of the measles vaccination program. During the COVID-19 pandemic, SARS-CoV-2 antibody and viral RNA testing has also been performed on the SPF colony.